Neurocognitive Mechanisms Underlying Children's Theory of Mind Development

DESCRIPTION (provided by applicant): As social beings, developing the capacity to communicate and interact with others, to acquire cultural knowledge, and to form relationships is essential for successful human growth. Central to these social- cognitive capabilities is the development of theory of mind - the understanding that the actions of self and others are attributable to internal mental states, such as beliefs, desires, intentions, and emotions. The importance of understanding mental states for social functioning is underscored in the case of autism;individuals with autism appear to have specific impairments in their understanding mental states, which results in profound deficits in communication, social interactions, and forming relationships. To understand the neural substrates of such impairments, research must first investigate the neural substrates of how theory of mind typically develops. Although numerous functional neuroimaging studies have examined theory of mind in adults and older children, there are almost no data on the neural correlates of theory of mind in young children. Research has shown that core aspects of theory of mind develop during the preschool years. One consistent feature of theory of mind development is that children's understanding of desires precedes their understanding of beliefs. In addition, to the extent that much older children with autism answer theory-of-mind questions correctly, they do so for questions about desires at an earlier age than for questions about beliefs. However, little is know about why there is this age lag in the development of belief reasoning versus desire reasoning. The main hypothesis of the proposed studies is that the developmental lag in belief reasoning versus desire reasoning hinges on the involvement of different cognitive processes which are supported by different neural circuitries maturing at different ages. The specific aims of the proposed project are (1) to determine the neural systems associated with belief reasoning versus desire reasoning and (2) to investigate the development of these neural systems in relation to children's understanding of desires and their understanding of beliefs. Across several studies, neurophysiological data (EEG and ERP) will be recorded as children perform tasks involving belief reasoning and tasks involving desire reasoning, as well as tasks involving reasoning about other mental states (knowledge, emotions). Both EEG and ERP measures will be investigated to allow for a diversity of tasks that can be used with children and to provide greater generalizability of the findings. PUBLIC HEALTH RELEVANCE: The project will provide insights into cognitive and neural underpinnings of the development of core social- cognitive abilities. Such insights will set the stage for greater understanding of the neural substrates of social- cognitive impairments in social and communicative disorders, such as autism.

Public health relevance
PROJECT NARRATIVE The project will provide insights into cognitive and neural underpinnings of the development of core social- cognitive abilities. Such insights will set the stage for greater understanding of the neural substrates of social- cognitive impairments in social and communicative disorders, such as autism.